Radiopathomic Modeling of Glioma Heterogeneity Throughout a Patient's Disease Trajectory

PROJECT ABSTRACT
The infiltrative nature of gliomas makes it difficult to define and treat the full extent of tumor using conventional
magnetic resonance imaging (MRI). Both standard of care and experimental treatment can further cloud
traditional imaging signatures, hindering accurate treatment delivery and response assessment. Accurate
methods for delineating the true extent of tumor are therefore desperately needed for directing treatments and
evaluating their effectiveness. Radio-pathomic mapping algorithms have emerged as promising tools to identify
microscopic infiltrating tumor cells and within lesion pathological heterogeneity. This proposal aims to externally
validate and integrate radio-pathomic models developed using autopsy and biopsy samples from two different
institutions, the Medical College of Wisconsin (MCW) and the University of California, San Francisco (UCSF).
The combined models will be further refined and developed with the inclusion of clinical information, novel deep
learning approaches, and finally the completion of a prospective multi-site clinical validation study.
In this proposal, aim 1 will focus on the external validation of radio-pathomic maps and their ability to
generalize when applied to external datasets acquired at various time points during a patient’s therapeutic
trajectory. Performance for identifying pathological measures of proliferation, cellularity, and molecular subtype
will be assessed in newly diagnosed patients. At tumor recurrence, each model will be evaluated to determine
how well they differentiate treatment effects from true recurrent tumor. Additionally, we will compare radio-
pathomic maps to metabolic measurements obtained with MR spectroscopy. Aim 2 will unify and refine the radio-
pathomic models by leveraging comprehensive datasets from both institutions. The impact of time between the
last MRI scan and death, timing since initial diagnosis, and other clinically prognostic variables on model
performance over time and generalizability to a patient's full trajectory will be investigated. Different strategies
for retraining models and incorporating data acquired from over the disease trajectory including deep learning
will also be explored. Aim 3 will test the ability of optimized radio-pathomic models to correctly identify regions
of glioma infiltration at diagnosis and tumor recurrence in a multi-site prospective clinical validation study, a
critical step for broader adoption and clinical translation.
Successful completion of this proposal will advance the field of radio-pathomics for glioma
characterization, offering non-invasive tools to aid in treatment planning, monitoring treatment response, and
guiding personalized therapies. The outcomes will contribute to the development of a robust and clinically
applicable framework for glioma management, ultimately improving patient outcomes and quality of life.

Public health relevance
PROJECT NARRATIVE This proposal will develop and validate radio-pathomic techniques for detecting brain tumor invasion beyond what is visible on anatomical MRI. We will using two complimentary radio-pathomic mapping techniques developed at MCW and UCSF to first determine how well they generalize in a multi-center, longitudinal study, then expand and combine our modeling approaches to determine how well they predict patient molecular subtype and tumor metabolic activity. Our resulting radio-pathomic maps will then be prospectively validated in the translational setting to determine how well they guide surgeons performing biopsies in the most invasive tumor regions.